Gut microbiome-related metabolites and cognitive impairment

Abstract
Cognitive impairment is a significant source of neurological disability, and a majority of cases are caused by
vascular contributions to cognitive impairment and dementia (VCID) and Alzheimer’s disease (AD). Differences
in the incidence among Black individuals compared to White individuals lead to a disproportionate burden of
cognitive impairment in this group. The REasons for Geographic And Racial Differences in Stroke (REGARDS)
Study is a longitudinal multi-racial study of 30,239 community-dwelling participants designed to enhance the
understanding of these conditions and identify potential contributors to racial disparities. Using our metabolomics
platform, our previous studies have shown that metabolites are independent risk factors for stroke and many of
these markers are synthesized by gut microbiota. Our studies further highlighted that metabolites can illuminate
racial differences in disease risk, and that gut microbiome-related metabolites are modifiers of the relationship
between dietary intake and stroke. In the current proposal, we will expand upon our findings and unravel the
relationships between gut microbiome-related metabolites, VCID and AD biomarkers, and subsequent cognitive
impairment. We seek to address our hypothesis in the following aims in the REGARDS study, with replication in
the Coronary Artery Risk Development in Young Adults (CARDIA) cohort: 1. To examine the association between
gut microbiome metabolites and CSVD brain MRI phenotypes in REGARDS and CARDIA, and assess for
differences by race. 2. To determine the association between gut microbiome-related metabolites and the
incidence and trajectory of cognitive impairment. 3. To determine the association between biomarkers of brain
amyloid β (Aβ+) status and cognitive impairment in REGARDS, and assess for effect modification by gut-related
metabolites. Collectively, these aims will provide insight into the relationships between diet and circulating
metabolites on the progression to cognitive impairment through CSVD and Aβ+ pathways. Our multidisciplinary
collaboration includes investigators who bring collective expertise in metabolite profiling, imaging markers of
VCID, epidemiology cohort studies, cognition and aging, and health disparities. Identifying markers that provide
insight in these mechanisms may provide actionable leads for future interventional studies, inform personalized
treatment targets, and ultimately may lead to novel gut microbial engineering therapeutics.

Public health relevance
Narrative Cognitive impairment manifests in later life from the accrual of exposures in the preceding decades, which also exhibit disparities by race. There is consistent evidence that mid- and late-life diet patterns are linked to cognitive decline, but the underlying pathways are incompletely understood. In this proposal, we will test the hypothesis that gut microbiome-related metabolites are associated with subsequent cognitive impairment, and influence the rate of conversion of amyloid- and vascular-related dementia; these studies will improve our ability to identify individuals at risk, identify potential reasons for racial differences in those risks, and clarify the role of gut microbiome-related metabolites in cognitive function over the lifespan.